Dissecting the Functional Consequences of Mutations in ZFP36L2 on Tumor Progression and Inflammation in the Tumor Immune Microenvironment of Colorectal Cancer

PROJECT SUMMARY/ABSTRACT
Colorectal cancer (CRC) is a devastating disease with no effective therapeutic options for patients suffering from
advanced metastasis. Immune checkpoint inhibitors (ICIs) offer promising treatment potential for a small subset
of patients with microsatellite instable (MSI)/mismatch repair deficient (dMMR) tumors. However, most CRC
patients have microsatellite stable (MSS)/mismatch repair proficient (pMMR) tumors that respond poorly to ICIs.
There is therefore an urgent need to identify novel targets and biomarkers of response to immunotherapy in MSS
tumors, which constitute over 90% of metastatic CRC. ZFP36L2, an RNA-binding protein mutated in 5-10% of
CRC, is a member of the TIS11 gene family which is known to suppress inflammation by blocking the expression
of proinflammatory chemokine and cytokine mRNAs in immune cells. Preliminary data from our lab suggests
that loss of ZFP36L2 function in human CRC leads to increased T cell recruitment into the normally
immunologically “cold” tumor microenvironment (TME) of MSS/dMMR TME. These data suggest that ZFP36L2
may also suppress the translation of cytokines and chemokines in CRC as a mechanism of immune evasion,
and further that ZFP36L2 mutations may give rise to increased immune cell infiltration into CRC tumors, which
may enhance responses to immunotherapy. To address this, we have developed a novel syngeneic mouse
ZFP36L2 knockout CRC organoid model and a ZFP36L2 knockout genetically engineered mouse CRC model.
These tools will allow us to delineate the ability of ZFP36L2 to regulate the inflammatory secretome of CRC
(Aim1) and assess how ZFP36L2 mutations impact the composition and functionality of the TME in CRC (Aim
2). This research will elucidate the functional consequences of mutations in ZFP36L2, whose function in human
cancer is poorly understood. More broadly, our work will increase our understanding of how tumors shape their
local immune environment to support disease progression. Our interrogation of the role of ZFP36L2 in CRC will
address critical unmet needs to develop novel treatment strategies for MSS CRC and identify clinically actionable
biomarkers of response to immunotherapy. This work has the potential to significantly improve the survival and
quality of life for CRC patients.

Public health relevance
PROJECT NARRATIVE There is an urgent need to identify novel targets and biomarkers of response to immunotherapy in microsatellite stable/mismatch repair-proficient colorectal cancer (CRC). This proposed research will delineate the influence of the frequently mutated RNA-binding protein ZFP36L2 on CRC disease progression and immune evasion. Utilizing a novel syngeneic mouse ZFP36L2 knockout organoid model, a novel ZFP36L2 knockout genetically engineered mouse CRC model, and patient derived organoid models, this proposal aims to advance our understanding of tumor-regulated inflammation and contribute to the development of new treatment strategies to improve the prognosis and quality of life for CRC patients.